DEPRESSION AS A RISK FACTOR FOR ISCHEMIC HEART DISEASE

This study will evaluate potential alterations in platelet function and sympathetic tone in patients with major depression. Preliminary data were analyzed, and results were used to prepare a grant application.